Development of Preventive Strategies and Therapy for HIV Infection

Since its formation, the Viral Oncology Section has conducted research on human immunodeficiency virus (HIV) disease, in addition to our studies on HIV-associated malignancies. The studies on HIV have focused on the HIV protease and the GagPol protease precursor. We found that the protease inhibitor GRL-142 also binds to and impairs HIV-1 integrase nuclear localization signal and potently suppresses highly INSTI-resistant HIV-1 variants. We have been conducting a trial of the anti-PD-L1 drug pembrolizumab and its effect on the HIV reservoir. In collaboration with Dr. Maldarelli in NCI, we have been studying the oligoclonal nature of HIV integration in patients on long-term anti-HIV therapy. Also, in collaboration with T.W. Chun and colleagues in NIAID, we have found that HIV in a multidrug resistant patient could be successfully treated with anti-CD4 domain 1 antibody and lenacapavir.